Southeast Center for Agricultural Health and Injury Prevention

Southeast Center for Agricultural Health and Injury Prevention
Project Summary/Abstract
The Southeast Center for Agricultural Health and Injury Prevention (SCAHIP) at the University
of Kentucky proposes to continue its long history of serving as one of the NIOSH Centers for
Agricultural Safety and Health for 2022-2027. The Center, founded in 1992 on a land-grant
university campus, provides multidisciplinary collaboration from colleges of agriculture,
engineering, public health, education, medicine, nursing and the Cooperative Extension Service
from universities in the Southeast. We propose 6 Research Core projects: Postsecondary-
Community Safe Farm Steward & Advocate Program; Timber Safe Resource Center: Reduction
of Central Appalachian Logging Hazards through the Implementation and Diffusion of a Tested
Logging Operations Safety and Health Management System; Farmer Mental Health in the
Southeast Region: Community Networking, Access and Support for Farmer Well-being;
Exposure Risk Assessment and Respiratory Disease Prevention Associated with Grain
Production; Vector-borne Disease Assessment and Prevention among Farmers and Forestry
Workers; and a Pilot/Feasibility Program. The Center’s theme, “Multidisciplinary partnerships to
improve agricultural safety and health in the Southeast,” is distinguished by our emphasis on
serving vulnerable farm populations while addressing persistent and emerging agricultural
safety concerns. The region served by the Center will continue to be 9 southeastern states of
AL, GA, KY, MS, NC, SC, TN, VA and WV. The Center will evaluate its impact on the following
priorities and NIOSH Strategic Goals in the agriculture and forestry sector: prevention of injuries
from unsafe equipment and work practices on farms; a reduction in logging injuries and
fatalities; providing training and information on resources and support for mental health among
the agriculture population; reduction in exposures and risks for respiratory diseases from grain
dust exposure; and surveillance and risk reduction for vector-borne diseases. Through our
Pilot/Feasibility, Outreach, and Emerging Issues program we will work with our many
interdisciplinary partners to continue address a wide variety of problems in our regions. The
Center benefits from strong institutional support from multiple colleges within the University of
Kentucky and collaboration with researchers and partners at many other universities,
professional organizations, and farm and forestry families in the Southeast. A major goal of the
SCAHIP leaders is to prepare the next generation for enjoying safer and healthier work on our
region’s farms and forests.

Public health relevance
Southeast Center for Agricultural Health and Injury Prevention Project Narrative In collaboration with regional stakeholders and our multidisciplinary team of investigators, the Southeast Center for Agricultural Health and Injury Prevention (SCAHIP) has developed a comprehensive plan which includes surveillance, measurement and assessment, training, intervention, and translational research projects that target important continuing problems in the agricultural and forestry sectors in the Southeastern US. The SCAHIP has invited a great number of collaborators to work together to produce measureable improvements towards safer and healther agriculture and forstry work practices and outcomes.